REGULATION OF CELLULAR GENE EXPRESSION BY HUMAN PAPILLOMAVIRUSES

The pathogenesis of cervical cancer is influenced by a variety of cytokines that regulate keratinocyte growth or mediate the host's response to papillomavirus (HPV) infection. Our studies have examined mechanisms by which HPVs perturb the ability of cervical keratinocytes to respond to or secrete specific cytokines. Keratinocytes were infected with high-titer recombinant retroviruses encoding the HPV-16 E6 or E7 genes alone or in combination and cytokine release was monitored by ELISA assay. E6 and E7 stimulated a 10 to 20-fold increase in release of interleukin-1alpha (IL-1alpha), a key mediator of inflammation and immunity. IL-1alpha release occurred selectively as secretion of the IL-1 receptor antagonist, a competitive inhibitor of IL-1 binding, was increased only slightly. In contrast, E6 and E7 decreased release of biologically active TGF-beta2, an autocrine growth factor that inhibits proliferation of normal keratinocytes. Furthermore, normal ecto-cervical keratinocytes and HPV-immortalized cells responded differently to these two cytokines. IL-1alpha stimulated proliferation of several HPV-immortalized and cervical carcinoma-derived cell lines whereas normal cells were not effected. In addition, low levels of TGF-beta stimulated proliferation and inhibited squamous differentiation of the immortal cells but not normal keratinocytes. TGF-beta also increased the number of epidermal growth factor (EGF) receptors by stimulating transcription of the gene. Molecular analyses indicated that both cytokines stimulated proliferation by induction of an autocrine growth factor, amphiregulin, a member of the EGF peptide family. Thus, HPV-16 E6 and E7 proteins perturb expression and responsiveness to cytokines that regulate keratinocyte proliferation and host response to infection. These results suggest that differential responsiveness to IL-1alpha and TGF-beta might provide a selective growth advantage for abnormal cervical cells in vivo.